Resubmission: Structure/Function Determinants of Puncture Wound Thrombus Formation

PROJECT SUMMARY/ABSTRACT
Scientific Premise and Prior Research: Puncture wounds, be they produced by accident, intent or medical
practice, e.g., surgery, can be a routine to major traumatic event. Moreover, drug aggravated bleeding is a major
limitation of current antiplatelet drugs that form a cornerstone of cardiovascular patient therapy and a potentially
major liability to any surgery. We contend that detailed structure understanding of the platelet centric responses
that occur within the actual puncture hole is essential to fill a void in prior research and yield an important
framework for the management traumatic injuries and common bleeding side effects.
Gap(s) in knowledge: Previous approaches to thrombus formation have focused mostly on examples in
which the exposed vascular matrix remains intact and therefore little to no bleeding occurs and have suffered
from the inability of 2P microscopy or SEM to assess platelet activation at the level of individual platelets.
From this circumscribed experimental perspective, a “Core and Shell” model of thrombus structure, i.e., a
horizontal core of matrix anchored, highly activated platelets covered by a shell of weakly activated platelets in
which signaling within the Core is thrombin-dependent and within the Shell is ADP/thromboxane-dependent
has emerged. We submit that this model may well be limited in its application to actual bleeding where the
wound is an open puncture hole.
Solution to problem: Taking alternate visualization approaches that determine the activation state of individual
platelets in 3D space, our Preliminary Studies have already yielded data redefining normal, bleeding cessation
as exemplified in a puncture wound model. Our data reveal a spatially dispersed, platelet activation pattern and
strong indications that initial steps in thrombus formation are dependent on the capture of platelet aggregates
that cap the hole from the outside rather than fill the hole. This has led us to formulate a new “Cap and Build”
paradigm. How both platelet-centric and coagulation factor cascade events can be integrated within the
paradigm is now an important question. To understand these multiple inputs through experimentation, we have
proposed Aims that focus first on signaling events, be they autocrine (platelet secretion, Specific Aim 1) or
exocrine (as inferred from the effects of anti-platelet drugs or DOACs, Specific Aim 2), and the importance of
platelet adhesion receptors (Specific Aim 3). We also propose to test how well the Cap and Build paradigm
apply to smaller, less traumatic injury.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE We submit that thrombus formation in response to normal, physiological bleeding produced by puncture wounds or biopsies or other causes is fundamental to human health and is still poorly understood. We do not yet have the penetrating ultrastructural analysis of a forming clot that is required to build conceptual paradigms based on a structural characterization of the actual clot that forms. The studies proposed test a novel clotting paradigm, Cap and Build, and should greatly increase the predictive value of that paradigm. In brief, the research should yield through signaling tests and adhesive mutant studies a sensitive, validated ultrastructural paradigm in which to assess bleeding effects and drug consequences that should be extensible with time and effort to many other systems including arterial bleeding, thrombosis, embolism, and DVT.